Novel coated nanostructured implant surfaces to increase osseointegration and decrease peri-implantitis in a physiologic rat model

PROJECT SUMMARY/ABSTRACT:
This R01 competing resubmission renewal is focused on establishing the efficacy of nanostructure technology
with a protective coating in increasing osseointegration, and minimizing bacterial proliferation and corrosion
around titanium dental implants. This is a continuation of our current grant, which developed and optimized a
coating for corrosion resistance on ceramic with the goal of producing fracture-resistant restorations. Our data
demonstrated excellent corrosion resistance, anti-bacterial and bone forming properties of an optimized silicon
carbide (SiC) coating and this competing renewal will provide an expanded application for this coating with dental
implants. The long-term goal of this research is to develop an implant which will increase osseointegration and
prevent peri-implantitis to improve long-term restoration outcomes. The overall objective is to critically evaluate
the anti-corrosive, anti-bacterial and bone integration properties of dental implants with a pioneering design that
will incorporate nanostructured topography and protective coatings, which we developed in the previous funding
cycle, using a rat model that will physiologically simulate the etiology of peri-implantitis.
This unique, translational research project will employ the use of a rat model with physiologically induced
bacterial-mediated peri-implantitis. A combination of nanostructure technology through anodization of the
titanium surface, customized for osteofunctional and anti-bacterial efficacy, will be applied in conjunction with
protective coatings (Silicon Carbide and Quaternized Silicon Carbide) developed during the last funding cycle.
This combination is expected to potentiate the osseointegrative, anti-bacterial and anti-corrosive properties of
both surface modifications to create a predictable implant restoration. Initial in vitro experiments will be conducted
to determine ideal nanostructure surface for osseointegration. We will coat these customized nanostructures to
develop a new implant design for placement in animal models to determine osseointegration, anti-bacterial and
anti-corrosive properties using state of the art nanoCT visualization of the in vivo pathogenesis of peri-implantitis.
We propose the following aims to test our central hypothesis: Aim 1: To optimize nanostructure design for
increasing osseointegrative potential on Ti surfaces in vitro; Aim 2: To optimize the effect of customized
nanostructured coated implant surfaces on bacterial adhesion and proliferation, and corrosion in vitro; Aim 3:
To determine in vivo the rate and amount of osseointegration in implants with customized nanostructure
topography during early and late stage implant placement in rabbits using stability evaluation, nano-CT
evaluation and histological analysis; Aim 4: To determine the effectiveness of customized nanostructured coated
implants in osseointegration and prevention of peri-implantitis in vivo in the rat model of polymicrobial peri-
implantitis, which physiologically mimics human peri-implantitis.

Public health relevance
PROJECT NARRATIVE The proposed study entitled “Novel coated nanostructured implant surfaces to increase osseointegration and decrease peri-implantitis in a physiologic rat model” is a study on the development of a new design and surface for dental implants that will not only increase bone formation and stability of the implant but also decrease bacteria from proliferating around the implants to minimize inflammation and destruction of the implant surface. This is very important to public health because the study will address how to minimize peri- implantitis, which is a disease around dental implants that leads to soft tissue inflammation, bone loss and eventually loss of the implant and the crown or bridge that is being supported. This will allow the patient or the dental consumer to protect his investment by paying for a product that will have more predictable success and will have minimal failure resulting from lost implants in the future.